Isolation of Liver Tissue RNA, Quality Assessment, and Arrays

This study will evaluate changes in hepatic gene expression in female B6C3F1 mice exposed to brominated and chlorinated dioxins or furans. Liver tissue from female B6C3F1 mice obtained from a NTP study entitled “Immunological Evaluation of the Relative Potency of a Single Oral Administration of Brominated and Chlorinated Dioxins and Furans in Female B6C3F1 Mice” was transferred to ILS